EXAGGERATED PLATELET REACTIVITY IN MAJOR DEPRESSION

This study is an amendment to SPID 3250. It will evaluate alterations in platelet reactivity and sympathetic tone in patients with major depression, and then re-evaluate these patients after 6 weeks of treatment with the anti-depressant, paroxetine. An additional 10 subjects who fulfill the DSM-IIIR criteria for major depression will also be studied.